Investigation of how RNA-directed feedback loops coordinate wound healing and regeneration

PROJECT SUMMARY/ABSTRACT
Life is dependent on the fundamental process of cellular migration for fertility, proper embryonic
development, and wound healing/regeneration. Developmental transitions during embryonic, fetal, and
post-natal maturation in metazoans are tightly controlled via a subset of conserved pathways characterized
as heterochronic gene regulators, which regulate the rate and timing of development. Many of the same
genes required for embryonic morphogenesis are also required for normal adult stem cell regeneration and
wound healing. The long-term goal of our lab is to understand how positive and negative developmental
regulatory loops between RNA processing proteins (RPP) and their downstream RNAs (microRNA and
mRNA) control wound-healing/regeneration/cell migration. Previous investigations of developmental
timing in worms, flies, and frogs have mainly focused on state transitions of stem cells from proliferative to
differentiated states or during metamorphosis. Little is understood regarding the combined spatiotemporal
regulation of normal adult wound repair and regeneration particularly, in mammals. Synchronization of
cell fate and cell migration in the early embryo is an example of where heterochronic genes are key to proper
mammalian development via spatiotemporal regulation. Our central hypothesis is developmental
pathways that regulate proper morphogenesis are similarly engaged during normal adult wound-
repair/regeneration. We propose certain injury conditions, may challenge normal wound repair and
regeneration via spatial and/or temporal dysregulation of developmental feedback loops leading to
incomplete repair or fibrosis.
The objective of this grant is to investigate heterochronic pathways that participate in RNA-directed
feedback loops during wound-healing and regeneration. Investigation into how these same heterochronic
pathways is conserved or altered during wound-repair and regeneration of will be done using 1) primary
and immortalized normal human epithelial cells and 2) established mouse models fibrosis.

Public health relevance
Project Narrative Numerous disease states ranging from excessive migration in pulmonary fibrosis, incomplete wound repair in uncontrolled diabetes, and the metastatic spread of aggressive tumors have altered cell migration. Several developmental pathways are re-expressed during injury under normal and diseased conditions. The goal of my lab is to further our understanding of wound-healing during normal compared to disease states using development as a road map.